SUBJECT MATTER EXPERT CONSULTANT FOR DRUG METABOLISM PHARMACOKINETICS [DMPK].

This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to understand the basis of pain and enhance clinical pain management.

Drug Metabolism Pharmacokinetics

The Contractor shall provide consulting support services to the NIH Blueprint Neurotherapeutics Network as
follows:
• Evaluate pharmacokinetics study protocols and data to identify potential drug discovery and development
challenges. Recommend strategies to address these challenges.
• Develop plans to assist NIH BPN staff in strategically managing pharmacokinetic programs which facilitate assay
development, exploratory chemistry, lead optimization, formulation activities, investigational new drug (IND)
enabling, and clinical studies.
• Assist NIH BPN staff to design investigative pharmacokinetics studies, including study strategy and experimental
design. Provide advice regarding recommended study milestones and prepare milestone reports are needed.
• Facilitate Lead Development Team discussions via telephone and email regarding assigned drug metabolism
and pharmacokinetics efforts.
• Analyze and interpret data for pharmacokinetics drug discovery, development, and translational projects.

Public health relevance
Subject matter expert support for developing non-addictive therapies for pain